The Investigator Development Core of SDSU HealthLINK Center for Transdisciplinary Health Disparities Research

INVESTIGATOR DEVELOPMENT CORE – Project Summary
The SDSU HealthLINK Center (Center) was established in 2018 to augment investigator, partner, and
institutional capacity for minority health and health disparities (MHHD) research. The goal of the Investigator
Development Core (IDC) is to enhance the career development of junior investigators, especially those under-
represented in the sciences, to conduct innovative minority health and health disparities research at SDSU,
SDSUIV, and with community partner organizations. To accomplish this goal, we propose the following four
specific aims that build on our successful Pilot Project (PP) program: 1) support the career advancement of
junior investigators through PP funding and training; 2) foster knowledge and skills transfer between Core
Leaders and PP by supporting cross core collaboration activities; 3) support the career advancement of a
broader audience of MHHD researchers through workshops; and 4) contribute to the Center’s measures of
implementation, engagement, satisfaction, and impact. To accomplish Aim 1, IDC will fund 10 PPs following
implementation of a Grant Writing Workshop to PP applicants designed to assist them in preparing a
competitive PP application. A Research Management Training Program will be delivered to PP Leaders and is
designed to foster successful project initiation and completion. Outreach and recruitment strategies will
leverage institutional resources and connections to maximize the recruitment of junior (i.e., post-doctoral
fellows, early-stage) investigators and those under-represented in the sciences. In this process, IDC strives to
create a diverse community of basic biomedical, behavioral/population, and clinical/health services researchers
working toward the common goal of optimizing health outcomes for all people. To accomplish Aim 2, IDC will
work closely with AC, RCC, CEC and newly hired RC faculty member to optimize the transfer of knowledge
and skills by and between Cores and Project Leaders. Our innovative career enhancement model allows junior
investigators to leverage the expertise of Center investigators, research staff, and senior mentors to generate
new knowledge that further enhances shared resources. To accomplish Aim 3, IDC will support the expansion
and reach of career enhancement workshops for a broader audience by working with previous PP Leaders in
preparing workshops and sharing research tools and resources through the Center’s Health Science Research
Portal. To accomplish Aim 4, IDC Co-Leaders and Coordinators will engage in implementation and
engagement tracking, and work with AC Evaluation team to obtain measures of satisfaction with IDC-
sponsored activities. They will also provide feedback to AC Evaluation team on measures of Center impact,
including methods for deriving evidence for impact on the investigator and impact on the field. Through these
efforts, IDC will strongly enhance junior investigator’s career development at SDSU or SDSUIV, which, in turn,
will greatly improve institutional capacity for MHHD research.